Administrative Core

PROJECT SUMMARY - Administrative Core
The Administrative Core will contribute to the overall goals of the Chicago Center for Diabetes Translation Research (CCDTR): 1) Provide core resources in Research Design, Data, and Analytics; Community Engagement & Population Health; and Accelerating HEalth by Advancing Diabetes Translation in Community Health Centers (AHEAD-CHC), that catalyze and support innovative, rigorous translational research to advance population health for the prevention and management of diabetes. 2) Increase the impact of rigorous diabetes translation research improve population health in Chicago and the nation by organizing partnerships across academic institutions and stakeholder groups into working groups that include: Aligning Clinician-Patient Decision Making; Community Drivers of Health; Implementation of Diabetes Prevention Interventions; Diabetes Cost Analysis and Economic Modeling; Organization and Financing of Diabetes Care in the Safety Net; Diabetes and Aging. 3) Attract and support investigators who are new to the area of diabetes translational research by providing education, mentoring, support for community and stakeholder engagement, pilot and feasibility seed grants, and access to critical translational research core resources.

The Center is composed of 2 Translational Research Methods Cores (Research Design, Data, and Analytics; Community Engagement & Population Health), an Enrichment Core, a Pilot and Feasibility Grant Program, and a Regional/National Resource Core for Accelerating HEalth by Advancing Diabetes Translation in Community Health Centers, 6 Working Groups help organize the diabetes translation researchers into collaborative groups to facilitate projects and access of members to mentorship, assistance, and partnership. A biweekly Zoom Center Conference will be a key feature that will bind the Center members together into an active, engaging community of diabetes translation researchers working on important problems together and helping each other. The Administrative Core oversees the entire Center. The Administrative Core is composed of the Center Co-Directors and the Co-Directors of the 2 Translational Research Methods Cores, national AHEAD-CHC Core, the Enrichment Core, and Pilot and Feasibility Program.

The Specific Aims of the Administrative Core are to:
1) Ensure that the Center catalyzes and supports innovative and rigorous translational research to advance population health for the prevention and management of diabetes in Chicago and nationally.
2) Oversee all Center operations, the translational research cores, and website.
3) Oversee the Enrichment Program and Pilot and Feasibility Program.